Comparative Study of Haitian and Miami Cohorts of Haitian-American and Haitian Immigrant Children with Sickle Cell Disease (CSHSCD)

Project Summary/Abstract
Sickle cell disease (SCD) is a chronic illness which affects mostly minorities in the United States. It is also a
prevalent disease in the Caribbean. Children afflicted with SCD are prone to many complications, such as
infections, pain and stroke. Newborn screening and comprehensive care with penicillin prophylaxis and
immunizations, among other standard-of-care measures, provide the chance to improve quality of life and give
the opportunity for survival. Haiti is one of the poorest countries in the Caribbean which does not count with
resources at the present time to implement some of these measures. Haitians are a significant minority in South
Florida, and are a third of the patients who attend the University of Miami Sickle Cell Clinic. This application
presents the opportunity for collaborative research in database development and cohort surveillance studies for
newborns and young children less than 6 years of age with SCD in the United States and Haiti. The research
question is to what extent there are differences in incidence and health outcomes in the two geographic areas
(Miami in Florida and in several Haiti sites). The proposal has 3 specific aims: 1. Determine the incidence of
newborns of Haitian ethnicity with SCD in Miami Dade County using available databases from newborn
screening. 2. Expand hospital-based newborn screening with point-of-care device and centralized laboratory
screening capability in Haiti so that SCD incidence is confirmed, allowing for comparison with Aim 1. 3. Examine
and compare barriers to care and health outcomes of the US-based Haitian ethnic cohort (with African-American
sickle cell controls) and Haitian cohorts. We will build on previously obtained data that the incidence of SCD in
Haiti among newborns is as high as 1 child out of 125 children born has SCD, and will expand the RED Cap
database of children followed in Cap Haitien, Haiti. PhenX standardized measures will be used to expand the
database for the Miami and Haitian sites. Demographics, changes in height and weight over time (growth),
anemia severity, SCD-related complications including stroke risk according to transcranial Doppler ultrasound
testing, treatment adherence, barriers to care via questionnaire assessment, acculturation in Haitian immigrants,
and mortality will be collected. The implementation of transcranial Doppler ultrasound (TCD), which is a non-
invasive method to screen for stroke risk, will be new in Haiti. We will accomplish this with staff training and tele-
mentoring. Central reading will be done at the University of Miami. We expect to learn from and benefit a low
resource setting in the Caribbean (Haiti), to impact Haitians living in the US, and promote strong international
collaboration.

Public health relevance
Project Narrative The observational study addresses clinical differences and barriers to care for young children of Haitian ethnicity and sickle cell disease in Haiti and in Miami. This Miami-Haiti network implements newborn screening in Haiti, provides health care to affected children including access to stroke risk screening, with capacity building and creation of a common element database. The knowledge gained will benefit Haitian immigrants in the United States and will provide the necessary framework to improve the quality of care of children with sickle cell disease in Haiti.